Biomarkers of Inflammation, Neurodegeneration and Age-Associated Cognitive Impairment

Project Summary
With a rapidly increasing population of aging Americans, cognitive impairment associated with
normative aging, or neurodegenerative diseases including Alzheimer's Disease and other related dementias
(ADOD), will place increasing burden on our public health infrastructure. Unfortunately, few effective
screening tools or therapeutic strategies exist, and many patients are refractory to treatment. Recent studies
suggest that altered neuroinflammatory signaling may play an important early role in normative aging, and
in ADOD, but the mechanisms by which the complex interaction of pro- and anti-inflammatory pathways
change over the lifespan, or modulate cognition, are unclear. For this reason, studies using animal models
that closely recapitulate normative human aging, but on a shorter timescale, are desperately needed to test
the overall hypothesis that rising levels neuroinflammation occurs prior to neurodegeneration and age-
related cognitive impairment, and represent a potential early marker. To address this need, the central goal
of my project will be to query the relationship between markers of neuroinflammation with brain morphology
and microstructure, and cognition, in naturally-occurring rhesus macaque model of age-related cognitive
impairment. I will use a combination of ultra-sensitive cerebral spinal fluid (CSF) protein biomarker assays,
Positron Emission Tomography (PET) imaging of activated astrocytes and microglia, high-resolution
Magnetic Resonance Imaging (MRI) of brain morphology and microstructure, and cognitive assessment for
spatial working memory. The strength of these studies lies in their potential to characterize novel biomarkers
of neuroinflammatory and neurodegenerative pathways that are associated with memory impairment, and
to identify new potential biomarkers that can serve as screening tools and future therapeutic targets.

Public health relevance
Project Narrative Cognitive impairment associated with normative aging and with the early stages of Alzheimer's Disease and other dementias (ADOD) often result in loss of independent living, but few effective therapeutic strategies exist to predict, prevent, or treat it. Recent studies have suggested that altered neuroinflammatory signaling may play an important early role in normative aging, and in ADOD, but the mechanisms by which the complex interaction of pro- and anti-inflammatory pathways change over the lifespan, relate to changes in brain microstructure/morphology, or modulate cognition are unclear. The proposed research in this application will use state-of-the-art neuroscience technologies (CSF protein biomarker assays, PET imaging of activated microglia, MRI, NODDI, and cognitive assessment) in a naturally-occurring animal model of age- related cognitive impairment to identify early markers of neuroinflammation and neurodegeneration that are associated with age-related changes in brain morphology/microstructure and cognition.